DEFINITION OF STATE OF RESISTANCE TO THYROID HORMONE

Generalized resistance to thyroid hormone (GRTH) is an inherited defect of reduced responsiveness to thyroid hormone often associated with growth retardation and learning disabilities. Our aim is to assess responses to thyroid hormone in non-resistant and resistant subjects in order to standardize a clinical procedure for the diagnosis of GRTH.